Maintenance and Regulation of Tendon and Ligament Maturation by TGFbeta Signaling

? DESCRIPTION (provided by applicant): We have previously shown that TGFβ signaling is a key regulator of the tendon cell fate: TGFβ signaling is a potent inducer of tendon markers and disruption of TGFβ signaling in limb bud mesenchyme resulted in failure of tendon development. This proposal is based on observations regarding the role of TGFβ signaling in later stages of tendon development. We find that disrupting the type 2 TGFβ receptor (TβR2) in tenocytes using the ScxCre tendon deletor resulted in tendon degeneration in early postnatal stages. Interestingly, embryonic development of the tendons was not affected and the tendons developed a robust and organized collagen matrix, but in early stages of postnatal development the movement of TβR2;ScxCre pups was perturbed and their tendons showed gradual loss of tendon markers followed by degenerative processes. Moreover, we find that tenocyte dedifferentiation was not due to an intrinsic loss of TGFβ signaling, since loss of the TβR2 in isolated patches of tenocytes did not have a similar effect. We therefore hypothesize that loss of TGFβ signaling results in disruptions to cell-cell or cell-matrix interactions in tendons leading o tenocyte dedifferentiation and tendon degeneration. The proposed project follows these observations in three major directions, the first aim is to determine if there is a developmental time window in which disruption of TGFβ signaling will lead to tendon degeneration and to develop more limited model of the phenotype that will enable following the full scope of the degenerative process and developing it as a system for analysis of tendinopathy. In the second aim we will investigate the cellular and molecular changes in the mutant tendons to identify the key features essential for maintenance of the tendon cell fate. Finally, in the third aim we analyze the role of activin signaling in this process based on preliminary results that show synergistic interactions between TGFβ and activin signaling.

Public health relevance
PUBLIC HEALTH RELEVANCE: Tendinopathy and tendon degeneration affects large parts of the population and result in considerable and prolonged morbidity and pain. We propose that analysis of tendon degeneration in the absence of TGF signaling may unravel issues relevant to the onset and progression of these conditions.